Identifying non-opioid strategies to manage oral cancer pain

PROJECT SUMMARY
An almost universal symptom of head and neck squamous cell carcinoma (HNC) is cancer-related pain. Oral
cavity and oropharyngeal cancers are even more painful than the rest of the head and neck anatomic sites.
HNC-associated pain frequently develops resistance to morphine and few strategies are available for effective
pain management after they develop resistance. In addition, the inevitable morphine dose escalation leads to
constipation, nausea, sedation, dry mouth, and myoclonus, which substantially decrease the patient’s quality of
life. Recent studies have also shown that morphine has undesirable immunosuppressive features. Through the
support of the parent R01 award, we have found that type-I interferon signatures underpin the immunogenicity
of HNC and made seminal contributions to the understanding of oncogenic suppression of type-I interferons by
promoting the rapid turnover of an adaptor protein, stimulator of interferon genes (STING). In addition to the
potential of STING agonists in reprograming the antigen-presenting cells to cross prime CD8+ cytotoxic T-
lymphocytes more effectively, we recently uncovered an unexpected yet powerful function of STING agonists
in promoting analgesia. Hosts that are deficient in the STING-type-I interferon pathway show significantly
elevated nociceptor excitability. We have found that common driver oncogenes for HNC initiation suppress
STING and lead to type-I interferon deprivation in the tumor microenvironment. In this supplement proposal,
we will provide transformative evidence to leverage type-I interferons for the management of HNC-associated,
morphine-resistant pain. To achieve this goal, we have generated novel and rigorous HNC models with high
fidelity resemblance to human HNC mutational features. We will integrate comprehensive modeling, behavior
studies, and single-cell technologies to identify non-opioid agents for HNC pain management.

Public health relevance
PUBLIC HEALTH RELEVANCE Pain is among the most common head and neck cancer symptoms and is rated the worst symptom reducing the patient’s quality of life. Head and neck cancer patients frequently develop resistance to opioids for pain management despite the often effective initial response. This supplemental proposal will take advantage of the existing infrastructure, models, and single-cell technologies, provided by the parent award, to advance the development of non-opioid agents for the management of head and neck cancer-associated pain.